Animal Research Support

The Comparative Medicine Branch (CMB) supports 117 active animal research projects for over 35 active scientists in the Division of Intramural Research as well as the Division of the National Toxicology Program. A daily inventory of approximately 17 thousand rodents is maintained. The Branch ensures that all animal use is performed humanely and in accordance with all Public Health Service policies and federal guidelines. The NIEHS has maintained full accreditation by the AAALAC, an internationally recognized independent program, since 1972.